POSTPARTUM CHANGES IN CEREBROSPINAL FLUID NEUROCHEMISTRY

Longitudinal studies demonstrate that the course of anxiety disorders and depression is affected by pregnancy and lactation, but physiological determinants of these mood changes remain to be clarified. This study is designed to determine changes which may occur in comparison to normal control women.